Microbial-based platform for assessing organ damage in alcohol use disorders (AUD)

Alcohol consumption is linked to various local and systemic organ damages. Research, including our own,
indicates that alterations in the gut microbiota play a significant role in alcohol's effects. Alcohol-induced
dysbiosis often leads to intestinal barrier dysfunction, worsening alcohol-related organ injuries. Interventions
targeting the microbiota have shown promise in mitigating dysbiosis, improving barrier function, and reducing
organ damage. However, the relationship between alcohol consumption, gut microbiota changes (dysbiosis),
and alcohol-related organ damage (AROD) is not well understood. Identifying gut dysbiosis linked to AROD,
termed "alcohol enterotypes," and understanding the mechanisms leading to organ damage from alcohol
consumption are essential for identifying high-risk individuals and developing targeted interventions.
Despite extensive research on the gut microbiota's role in alcohol-related diseases, a clear definition of alcohol-
induced dysbiosis is lacking. We hypothesize that specific microbiota enterotypes associated with alcohol
consumption predict AROD. In this study, we aim to develop a comprehensive, web-based knowledge module
that integrates all available microbiota, metabolites, and host pathways to map microbial signatures and
mechanisms involved in AROD. The data-driven alcohol enterotypes will be tested and fine-tuned in relation to
clinical outcomes in real-world settings. By conducting this population-based validation study, we will optimize
our platform's performance, promote its widespread adoption, and support collaborative efforts in alcohol
research.
These studies will provide, for the first time, detailed insights into the role of dysbiosis in alcohol-induced organ
damage and identify alcohol enterotypes to inform risk assessment and personalized interventions targeting the
microbiota.

Public health relevance
Alcohol consumption is linked to various organ damages, significantly influenced by gut microbiota alterations. To better understand this relationship and develop targets for future interventions, we aim to identify "alcohol enterotypes" by integrating microbiome-host data from multiple studies using advanced machine learning algorithms. Leveraging our unique sample archives and population approaches, we will create a comprehensive module that predicts alcohol-related organ damage (AROD) and can be widely adopted in clinical settings.